Training & Dissemination Core

The overall goal of the CMITT Training program is to teach scientific advances made by biomedical researchers using
PET/MR, while the main objective of our Dissemination program is to inform and educate the broader scientific
community about the technical capabilities and accomplishments of simultaneous PET/MR. Together the two goals
promote and enable the broadest and most adept possible use of our PET/MR technologies. PET/MR is a young
modality that is technically complex, with a fast pace of growth in technology development and an increasing number
of sites nationwide. This can result in a hyper-competitive environment where sharing technology among centers is
not the norm. This is the very motivation behind making Training and Dissemination a cornerstone of our CMITT
program to aim at breaking down barriers through cultivating collaborations, providing numerous opportunities for
training physicists, engineers, radiochemists, and clinicians, and supporting avenues of broad dissemination. The
unique opportunity to develop PET/MR technology that is not tied to a specific manufacturer means that CMITT is the
first center, to our knowledge, to have access to both simultaneous PET/MR scanners available on the market today
from Siemens and GE with very strong collaborations in place with both manufacturers. With this Innovation Hub
comes also a unique opportunity for Training and Dissemination to the entire PET/MR community. To achieve this
goal requires a user community that is experienced in the utilization of imaging systems and working with and
interpreting image data sets. Thus, the training and dissemination initiatives are an essential component and
cornerstone of our mission.